SibWatch: Optimizing Intervention Options for Infants and Toddlers with a High Likelihood for Social Communication Delays and Language Disorder

Abstract
Autism is a neurodevelopmental condition that is highly prevalent and that comes at high cost to affected
children and their families. The costs of autism can be attributed, at least in part, to the effects of the condition
on children’s social communication and language development. Younger siblings of autistic children (HL-Sibs)
are highly likely to receive a future diagnosis of autism and/or language disorder themselves. Even those HL-
Sibs who are not diagnosed have an increased likelihood of displaying differences in social communication and
delays in language development. There is increasing support that preemptive interventions may influence
caregivers’ use of strategies that scaffold development and translate to effects on social communication and
language skill in HL-Sibs. However, prior studies of preemptive interventions have been limited by inclusion of
samples that are homogenous in race, ethnicity, and socioeconomic status, likely reflecting those families who
can readily access the medical centers and academic institutions conducting this research. Additionally, past
investigations suggest that effects of preemptive interventions may (a) yield only indirect effects on child social
communication and language, and (b) vary according to child and caregiver factors, but no previously identified
mediators or moderators of preemptive intervention effects have been replicated, and many factors that likely
explain or influence differential intervention effects have not yet been explored. Further, the extant literature
testing the efficacy of preemptive interventions has administered treatments across a broad range of child
ages, and we do not yet know precisely when preemptive treatment is most likely to yield favorable effects.
Finally, some studies have reported high rates of attrition amongst families assigned to treatment, suggesting
that caregivers may not find preemptive interventions to be acceptable. The present study will, thus, evaluate
the efficacy of ImPACT, an intervention that is established for use with autistic children and that has amassed
some past empirical support as delivered in vivo in HL-Sibs, as administered by telehealth (hereafter referred
to as tele-ImPACT) relative to a no-treatment control for effects on caregiver strategy use, proximal child skills,
and distal child social communication and language in a large, representative sample in the context of a
rigorous randomized clinical trial. Advanced analytic approaches will be employed to test numerous putative
moderators and mediators of tele-ImPACT effects, and qualitative approaches will be utilized to assess the
acceptability of the candidate treatment amongst caregivers. INNOVATION AND IMPACT: This innovative and
interdisciplinary study is expected to (a) provide empirical support for a novel preemptive intervention that is
theoretically motivated and developmentally informed, as well as accessible for and acceptable to families, and
(b) lend new insights into the developmental windows in which, mechanisms by which, and the subgroups for
which this intervention works. Such findings would have strong implications for theory, research, and clinical
practice in young children at elevated likelihood for autism and developmental language disorder.

Public health relevance
Project Narrative This rigorous randomized controlled trial will evaluate the efficacy and acceptability of a preemptive, telehealth intervention (tele-ImPACT) in a large, representative sample of younger siblings of autistic children, who are known to be at high likelihood of receiving a future diagnosis of autism and developmental language disorder (HL-Sibs). If our hypotheses are supported, this innovative and interdisciplinary study will provide empirical support for a novel approach to treatment that is theoretically motivated and developmentally informed, as well as accessible for and acceptable to families, and will lend new insights into the developmental windows in which, mechanisms by which, and subgroups for which the treatment works. Such findings would have strong implications for research, theory, and practice in young children at risk for autism and language disorder.